CRCNS: Dissecting Directed Interactions Amongst Multiple Neuronal Populations

Nearly all brain functions involve activity that is distributed across multiple areas. To understand these
functions, it is critical to understand the flow of signals across this distributed network. To date approaches
to understanding inter-areal signaling have been limited in several critical ways. First, they often focus on
single neurons or a few voxels to summarize an area’s activity—an impoverished sample of the intricate
neuronal population activity patterns that are known to represent and transmit information. Second, prior
approaches often consider only pairwise inter-areal interactions, though the relevant network of areas is
often much larger. Third, they rarely consider the concurrent flow of signals both from and to any given
node in the network. In this project, we aim to overcome all three of these limitations. In Aim 1, we will
develop and validate statistical methods that allow us to assess the directed, multi-dimensional flow of
neuronal population signals among multiple (more than two) brain areas. We will identify directed
interactions based on if the activation of a population activity pattern in one brain area tends to reliably
precede the activation of a population activity pattern in another brain area with a consistent time delay. In
Aim 2, we will refine and deploy the methods we develop to assess signal flow across multiple stages of
the macaque visual system, an ideal testbed given a great deal of prior work on the anatomical and
functional properties of the sampled areas. Specifically, we will record hundreds of neurons distributed
across different layers of primary visual cortex (V1), V2, and V3. We will determine how columnar
interactions within each area interact with feedforward and feedback processes, at a laminar level. Our
project aims to provide insights that will strongly advance understanding of fundamental aspects of cortical
function—how neuronal populations communicate with each other and how that communication relates to
cortical processing. We expect the understanding we gain, and the analytic and conceptual tools we
develop, will be broadly applicable across different brain systems. Our ambitious goals will be
accomplished by pooling complementary expertise of three PIs, building on a successful collaboration that
has extended over many years.

Public health relevance
This project aims to determine the principles by which neuronal populations communicate with each other across multiple brain areas. The misregulation of inter-areal signaling is thought to be central in psychiatric disorders like schizophrenia and autism. By understanding how communication is implemented and modulated, we will be better placed to understand these disorders and develop treatments for them.